The role of microglial glutaminase in HIV-induced sleep deficits

PROJECT SUMMARY
Despite the effectiveness of antiretroviral therapies, virologically suppressed people with HIV (vsPWH) are at a
higher risk for comorbidities such as neurocognitive, neuropsychiatric, and sleep disorders. Notably, 50-70% of
vsPWH experience symptoms of insomnia, including trouble falling or staying asleep, poor sleep quality, and low
daytime energy levels—rates 2.5 times higher than the general population. This exacerbates their health burden
significantly. Sleep disorders and inflammation are linked. Sleep disturbances can trigger inflammation, and
systemic inflammation may lead to neuroinflammation, disrupting sleep patterns. In vsPWH, elevated CNS
inflammatory markers and distinct microglial activation suggest that microglia-mediated neuroinflammation could
underlie HIV-related sleep deficits. Nonetheless, the microglial molecular landscape and its role in sleep
phenotypes in murine NeuroHIV models remains understudied. Another line of research highlights the
importance of microglia in regulating extracellular glutamate in the brain, a neurotransmitter linked to HIV-
induced neurocognitive deficits. Glutaminase (GLS1) is the primary enzyme for glutamate synthesis and is
upregulated in activated microglia. Using our brain-penetrable GLS1 inhibitor, JHU-083, we have shown that
inhibiting microglial GLS1 improves cognitive deficits in disease models of neuroinflammation, including the
EcoHIV-infection murine model of HIV. More recently, we found that EcoHIV-infected mice exhibit decreased
sleep amount in the early rest period and increased sleep fragmentation, similar to what has been reported in
vsPWH, and that JHU-083 could attenuate these deficits. Thus, we hypothesize that increased microglial GLS1
activity contributes to HIV-induced sleep disturbances, and inhibiting microglial GLS1 will alleviate sleep deficits.
We will take the following steps to explore this understudied area of research: 1) characterize the sleep
phenotypes in two murine NeuroHIV models - HIV-infected hu-BLT-hIL34 mice and EcoHIV-infected C57BL/6J
mice using the piezoelectric sleep recording system and EEG; 2) characterize microglia activation, neuronal
activity, neuroinflammation, and microglial transcriptome in the two NeuroHIV models and 3) determine whether
selective inhibition of microglial GLS1 using a hydroxyl dendrimer-GLS1 inhibitor delivery system will ameliorate
HIV-induced sleep deficits and normalizes microglia activation and neuronal activity change, neuroinflammation,
and inflammatory/sleep-related microglia molecular signatures. Successful completion of these goals will lay the
groundwork for developing novel mechanism-based therapeutics targeting sleep disturbances in vsPWH.

Public health relevance
Project Narrative Sleep deficits pose a significant challenge in virologically suppressed people with HIV (vsPWH). The underlying molecular mechanisms and the specific role of microglial glutaminase in these sleep disturbances are poorly understood, hindering the development of targeted interventions. In this study, we aim to elucidate the role of microglial glutaminase in HIV-induced sleep deficits and assess whether its inhibition can reverse the sleep deficits and associated microglia molecular alterations in two murine NeuroHIV models, potentially alleviating sleep disturbances in vsPWH.